Administrative Core

The goals of the Administrative Core are to provide all projects within the Lymphoma SPORE with centralized leadership and administrative support, and to ensure effective communication among all Projects and Cores. Through this work, the Administrative Core will ensure the Program’s overall objectives are being met. To achieve this goal, Core leaders Drs. Helen Heslop and Malcolm Brenner will arrange internal group meetings, including a monthly investigator meeting, executive committee meetings, and invited research lectures. The Core will oversee the overall fiscal and budgetary management of the SPORE and assist each project and core leader to achieve their goals, with a particular focus on assisting budgetary planning. Over the last 14 years of funding, this Core has monitored each project with input from the Executive Committee and Internal and External Advisory Boards, and modified projects and incorporated new directions as necessary. For the current proposal, the Administrative Core leaders will ensure continued SPORE oversight by convening meetings of the Scientific Advisory Board, which consists of both internal and external investigators with expertise in the field and assessing and implementing their recommendations. The Core also coordinates input from patients with lymphoma This Core will also coordinate the administration of the Developmental Research and the Career Enhancement Programs to ensure that the objectives of these programs are being met. This Core has the discretionary funds to support new research opportunities or unexpected costs. Finally, the Administrative Core will communicate with the NCI program staff and encourage and facilitate collaboration with other NCI translational initiatives.

Public health relevance
The Administrative Core supports the leadership of the overall Lymphoma SPORE to facilitate cooperation and communication between all Projects and Cores for the successful completion of the proposed research. This Core organizes meetings to monitor progress and promote collaboration and obtains external advice on program performance from Internal and External Scientific Advisory Boards. The Administrative Core also co-ordinates input from patient representatives.